NCTN Deep South Research Consortium

ABSTRACT
The University of Alabama at Birmingham (UAB) O’Neal Comprehensive Cancer Center (O’Neal) has a long
history of participation within the National Clinical Trials Network. Specifically, UAB was a founding member of
GOG, and has been a member of RTOG, ECOG, ACRIN, CALGB, NSABP, and SWOG. O’Neal is a current
member of the ECOG-ACRIN, NRG, and SWOG cooperative groups. It is our intention to continue as a leading
contributor of scientific leaders and clinical trial participants to the NCTN Program in the U.S. and particularly in
the Southeast. To accomplish this overall vision, we propose to further enhance the involvement of existing
O’Neal leadership in NCTN Center related clinical and translational research and to develop the next
generation of NCTN Center scientific leaders within O’Neal. In addition, we will further refine a clinical trials
process within O’Neal that optimizes accrual of potentially eligible cancer patients and patients at risk for
cancer to NCTN Center clinical trials. Finally, we will increase minority accrual to NCTN Cooperative Group
trials though our patient population.

Public health relevance
PROJECT NARRATIVE This proposal will ensure that the NCTN Program is provided access to the O’Neal Comprehensive Cancer Center clinical and translational investigators with a broad interest in cancer biology and experimental therapeutics. O’Neal staff and the clinical trials office will administer and support NCTN trials. Importantly, this proposal will also provide NCTN clinical trials access to our patient population that based upon its demographics and socioeconomic status is distinct from other areas in the country.